Advanced Training in Environmental Health Sciences

PROJECT SUMMARY
This is the competing renewal application for a highly successful T32 program that has trained more than 200
predoctoral students in toxicology/environmental health sciences (EHS) over the last 45 years. The objective of
this predoctoral program is to train the next generation of environmental health scientists through interdisciplinary
research and coursework that addresses issues of direct relevance to the NIEHS mission. We are requesting 2
years of support for each of 8 predoctoral trainees beginning after their first or second year in a PhD degree
program. Trainees are recruited from several UC Davis graduate programs that provide disciplinary training
relevant to EHS, including toxicology, cell and molecular biology, exposure assessment, chemistry, pathobiology,
epidemiology, neuroscience, immunology, and genetics. The training faculty – 35 active researchers from 20
departments - have substantial experience mentoring predoctoral students. Faculty research focuses on
mechanisms by which environmental factors contribute to human disease and encompasses diverse areas within
EHS. Close collaboration among training faculty members, through joint participation in Centers and Graduate
Programs as well as joint funding, promotes interdisciplinary approaches to EHS research. Trainees have access
to advanced technologies, such as proteomics, epi/genomics, and metabolomics, state-of-the-art imaging,
genetically modified organisms, and inhalation facilities for rodents and non-human primates. A strength of EHS
research at UC Davis is the vertical integration of studies directed towards understanding environmentally
induced disease. Complementing human clinical samples and epidemiologic studies, students have access to
diverse animal models, including nonhuman primates, and ranging through nontraditional models in the lab to
field studies of populations. In these models, students typically initiate molecular, cellular and/or tissue studies
under the guidance of their faculty mentor and with input from the training faculty. The training program leverages
the activities and resources of research centers and programs to provide synergy between disease prevention
and public health while interacting with students early in their scientific training. The training program
emphasizes practical instruction in scientific writing and communication of scientific findings to peers and lay
audiences through chalk talks, annual retreats, trainee mini presentations for invited speakers, outreach activities
with community groups, and participation in national meetings. Two key events expose trainees to emerging
concepts, controversies, and technologies in environmental health. The first is a seminar series featuring leading
environmental health scientists that is organized and managed by the trainees themselves. The second is a
summer course in which trainees explore a current issue relevant to environmental health under the close
guidance of training faculty. Trainees receive training in responsible conduct of research as well as rigor and
transparency woven into these events but also in special sessions. The training program has an excellent track
record of training leaders in EHS.

Public health relevance
PROJECT NARRATIVE The Advanced Training in Environmental Health Sciences program at UC Davis provides unique training in environmental health sciences (EHS) to predoctoral students to prepare them for diverse careers focused on the impacts of environmental factors on human health and disease. This program builds on existing interdisciplinary and collaborative research strengths at UC Davis, with vertical integration of studies at the molecular, cellular, organismal, and population levels directed toward understanding environmentally-induced disease. Trainees will receive a combination of didactic and experiential training to promote understanding of current and emerging concepts, controversies andtechnologies in environmental health, as well as a deep appreciation of responsible conduct of research, including rigor and reproducibility while working with diverse collaborators.